Missouri Department of Health and Senior Services Flexible Funding Model

Project Summary/Abstract—Missouri FFM (Overall)
The Missouri Department of Health and Senior Services (DHSS) has had a Bureau
specializing in food safety since shortly after the passage of the Food, Drug, and
Cosmetic Act. Today, that Bureau has evolved into the Bureau of Environmental Health
Services, but food safety remains one of its chief responsibilities. The Bureau’s retail
and manufactured food regulatory programs conduct various compliance, enforcement,
and outreach activities to promote food safety and protect public health. DHSS has
aligned its efforts with those of the U.S. Food and Drug Administration to maximize
effectiveness and efficiency. This project includes a proposal for DHSS to continue
previous work on national program standards and education/outreach, as well as to
improve regulatory oversight of dietary supplements. The goals and outcomes of this
proposal include the following:
1. Protect public health.
2. Advance efforts for a nationally integrated food safety system.
3. Maintain conformance to the MFRPS.
4. Establish a dietary supplement regulatory program.
5. Maintain a Food Protection Task Force.
As a result of these goals and outcomes, DHSS will advance efforts in Missouri towards
an effective and efficient nationally integrated food safety system and reduce foodborne
illness hazards in plants that manufacture, process, pack, or hold foods.

Public health relevance
Project Narrative—Missouri FFM (Overall) This proposal for RFA-FD-23-027 is intended to improve food safety in Missouri and nationally. Through conforming to national standards and initiatives, the Missouri Department of Health and Senior Services’ food safety programs will apply the best practices necessary to integrate with other state and federal programs to reduce foodborne illness hazards at facilities under its regulatory jurisdiction.